The Clinical Applications of the Difference in Estimated Glomerular Filtration Rate by Cystatin C vs. Creatinine (eGFRDiff)

PROJECT SUMMARY
This is an initial submission of a K23 application by Dr. Alison Potok, under the mentorship of Dr. Dena Rifkin,
at the University of California San Diego (UCSD). This proposal will establish Dr. Potok as an independent
investigator, and will evaluate the clinical applications of the difference in estimated glomerular filtration rate by
cystatin C (eGFRCys) vs. creatinine (eGFRCr), for prognosis in the long-term and drug dosing in the short-term.
Candidate: Dr. Potok’s training objectives and career goals through this proposal include: 1) to become an
expert in geriatric nephrology and proficient in pharmacology and drug dosing in the elderly; 2) to develop skills
in advanced statistical methods, epidemiology, manuscript and grant writing; 3) to learn the necessary skills to
design and conduct a clinical study and develop a research team. She has assembled a multidisciplinary
mentorship team comprised of a primary mentor, Dr. Rifkin, an established leader in geriatric nephrology, and
the following additional co-mentors and collaborators: Dr. Ix, an expert in nephrology clinical trials; Dr. Moore,
an authority in geriatric medicine and aging research, Dr. Gutierrez, an expert in kidney disease with extensive
experience and insight to the REasons for Geographic and Racial Differences in Stroke (REGARDS) study
utilized for Aim 2; Dr. Katz, the Director of Biostatistics at the University of Washington, who has worked
extensively with Drs. Rifkin, Ix, and Potok; Dr. Hallan, Professor of Medicine with expertise in decision curve
analysis and extensive experience in the Norwegian Nord-Trondelag Health Study (HUNT) utilized for Aim 1.
Research: Most patients with chronic kidney disease (CKD) will not progress to end stage kidney disease
(ESKD) due to the competing risk of death. Frailty may increase the risk of death vs. the risk of ESKD. The
current kidney failure risk equation (KFRE) and mortality risk equation in kidney disease (MREK) do not
account for frailty. In preliminary work, Dr. Potok has showed that the difference in eGFR by cystatin C vs.
creatinine (eGFRDiff defined as eGFRCys – eGFRCr) is associated with risk of incident frailty and death.
Moreover, Dr. Potok’s preliminary results show heterogeneity across the spectrum of eGFRDiff regarding
which marker between cystatin C vs. creatinine is the best surrogate for true kidney function. The overall
hypothesis is that eGFRDiff can be used to guide clinicians on whether to start preparing patients for renal
replacement therapy and with medication dosing. In Aim 1, she will determine whether the inclusion of
eGFRDiff, as a marker of frailty within the KFRE and MREK will improve assessment of the competing risk of
ESKD vs. death in older adults. This Aim will be conducted in participants aged >65years with CKD of the
HUNT study, an exclusively White European population. In Aim 2, she will explore the competing risk of ESKD
vs. death in a biracial American population in REGARDS. In Aim 3, Dr. Potok will examine whether eGFRDiff
could be used to determine those in whom eGFRCr should not be trusted for drug dosing, and eGFRCys should
be used instead, with vancomycin as the prototype medication.

Public health relevance
PROJECT NARRATIVE Kidney function is typically estimated using serum creatinine, although this may be less reliable at the extremes of muscle mass; Dr. Potok’s preliminary work demonstrated that the difference in estimated glomerular filtration rate by cystatin C (eGFRCys) vs. creatinine (eGFRCr) holds information on functional status, frailty, and risk of death in older adults. The objective of this proposal is to determine the clinical applications of this difference (eGFRDiff = eGFRCys – eGFRCr), in terms of both prognosis and treatment. Results from this study will provide arguments to change nephrologists’ behavior regarding referral for dialysis preparation, and to change which marker between serum creatinine and cystatin C should be trusted to estimate kidney function when dosing medications.